3D real-time super-resolution cavitation mapping in laser lithotripsy of urinary stone disease

Title: 3D Real-time Super-resolution Passive Cavitation Mapping in Laser Lithotripsy of Urinary Stone
Disease
Abstract:
In the United States, 1 in 11 individuals will experience a urinary stone disease (USD) in their lifetime. Laser
lithotripsy (LL) via ureteroscopy, in which pulsed laser light is used to progressively break the stones, has become
the choice of treatment for USD patients. In particular, “dusting” mode with low pulse energy and high frequency
has gained clinical popularity over “fragmenting” mode because of the fine dust produced, which eliminates the
need for basket retrieval and ureteral access sheaths, and thus greatly shortens the procedure time. Growing
evidence by us and others have discovered that cavitation bubble collapse plays a significant role in stone
dusting by Ho:YAG lasers, and maximizing cavitation activities is critically important for improving LL efficiency.
Despite the growing enthusiasm, the exact mechanism of cavitation in LL is not well understood and the optimal
LL settings for efficient dusting have not been defined. Such a paucity of knowledge is partially due to the lack
of imaging technologies for real-time feedback of cavitation activities during the LL treatment. B-mode ultrasound
imaging (or active cavitation mapping) is compatible with LL, but cannot image the short-lived transit bubbles
that undergo inertial cavitation and may also interfere with the bubble dynamics. Other imaging technologies,
such as x-ray CT, fluoroscopy and MRI, cannot detect cavitations due to the lack of contrast. In light of the clinical
need for more efficient LL, we propose to develop 3D super-resolution passive cavitation mapping (3D-SR-PCM)
that (1) is totally noninvasive and fully compatible with the LL treatment; (2) is capable of real-time monitoring of
the 3D cavitation activities at clinically-relevant depths (>10 cm deep) without background interference; and (3)
can achieve a cavitation localization resolution of ~50 µm, which is 10-fold better than the B-mode ultrasound
imaging. Our long-term objective of this project is to better understand the therapeutic impact of cavitation in
LL treatment, and develop more efficient LL with less adverse effects. Our central objective of this proposal is
to develop, validate, and optimize a safe, reliable, and precise imaging technology for real-time analysis of 3D
cavitation activities during LL treatment. We will pursue three specific aims: (1) develop the first 3D-SR-PCM
system with super-resolution bubble localization, automatic fiber tracking, and real-time cavitation analysis; (2)
thoroughly validate and optimize the 3D-SR-PCM system on kidney phantoms, and identify the most relevant
cavitation characteristics with stone damage under clinically realistic settings; and (3) apply the optimized 3D-
SR-PCM system on a swine model in vivo to evaluate the treatment efficiency with cavitation-imaging guidance,
and demonstrate its clinical feasibility through a pilot study on USD patients. The proposed 3D-SR-PCM is timely
and well justified, considering the growing USD epidemic and the rapid advance in LL technology. We expect
the outcome of this project will provide an enabling tool for optimizing the clinical LL strategies, and is anticipated
to impact the long-term surgical management of USD and further advance the LL technology.

Public health relevance
Narrative: Urinary stone disease (USD) is on the rise and represents the second most costly urologic condition in the US, with a healthcare cost over $10 billion per year. Despite the growing clinical enthusiasm and rapid development of new technologies in laser lithotripsy (LL), which is the current treatment of choice for surgical management of USD, the fundamental theory about cavitations in LL has been lacking, hindering the efforts to reduce procedure time and improve clinical outcome. In this project, we propose to develop the 3D super- resolution passive cavitation mapping technology for real-time analysis of the cavitation activities during LL, which will provide valuable information on optimizing the LL treatment strategy for USD patients.